Parsing molecular determinants of asymmetry in planar cell polarity signaling

PROJECT SUMMARY/ABSTRACT
Conotruncal heart malformations are the most common congenital heart disease. Genes associated with planar
cell polarity(PCP) signaling are implicated in the etiologies of conotruncal heart malformations, as PCP signaling
is necessary for the coordinated cell movements needed for proper outflow tract development. The broad
objective of this proposal is to determine the basic molecular mechanisms of this key developmental signaling
pathway, which are currently poorly understood. Establishment of PCP involves sorting PCP-associated proteins
into complexes with distinct compositions that are distributed to mark a vector of polarity used for downstream
readouts, such as coordinated cell movement. These complexes physically interact between adjacent cells to
facilitate alignment of intracellular polarity vectors across whole tissues, aligning with broader axes, exemplified
by the proximal-distal axis in the Drosophila wing. Complexes are linked by trans intercellular homodimers of the
PCP protein Flamingo (Fmi), with PCP proteins Frizzled(Fz) recruited to one side of the cell-cell junction and
Van Gogh (Vang) recruited to the other. Previous work suggests that Fz interacts laterally with Fmi and changes
Fmi homodimer affinity to preferentially bind Fmi:Vang complexes. Additional work suggests a novel, adhesion-
independent role for Fmi in modulating Fz binding to its downstream signaling partner Dishevelled (Dsh). Fz-
Dsh binding is known to be sensitive in a dose-dependent manner to PI(4,5)P2. Thus, this work investigates how
interactions between Fmi and Fz drive two key aspects of early establishment of planar cell polarity. I hypothesize
that lateral interactions between Fmi and Fz I. promote interactions favoring the formation of intercellular trans
interactions with Fmi:Vang complexes, and II. amplify PCP signaling through an adhesion-independent,
PI(4,5)P2-mediated feedback loop that recruits cytosolic signaling partners. Aim 1 will characterize the
asymmetric interactions between Fz:Fmi and Fmi:Vang complexes by reconstituting the proteins into a lipid-
nanodisc system, using total internal reflection fluorescence (TIRF) microscopy to measure asymmetric binding
affinity, and using cryogenic electron microscopy to identify structural determinants of asymmetry. Aim 2 will
characterize a potential PI(4,5)P2-mediated feedback loop by characterizing PI(4,5)P2 availability, determining
the Fmi-dependence of PI(4,5)P2 levels near PCP complexes, examining whether recruitment of Skittles, a lipid
kinase that produces PI(4,5)P2 can rescue Dsh binding in a Fmi null phenotype, and investigating whether Fmi
can directly bind Skittles. This project thus sets the stage for the development of a detailed mechanistic
understanding of PCP, which is essential for understanding normal heart development as well as the origins of
conotruncal heart disorders. The applicant will receive additional training from expert mentors in membrane
protein biochemistry and cryogenic-electron microscopy, in single-molecule biophysics, and training in
Drosophila genetics, building an excellent foundation for an independent research career working on the
molecular mechanisms that underpin human development and physiology.

Public health relevance
PROJECT NARRATIVE Congenital heart diseases make up nearly half of all birth defects, and present a significant economic burden, amongst which conotruncal heart malformations are the most common. This proposal investigates molecular mechanisms behind planar cell polarity signaling, which is necessary for proper heart development and implicated in the pathology of conotruncal heart malformations. Understanding the precise functions of these proteins opens up opportunities for therapeutic development in addition to contributing to knowledge of this key developmental pathway and its role in cardiac disease.